HCM Strategists proposal for: All of Us Research Program Engagement and Retention Innovators (OT2)

Building a participant community for the All of Us Research Program that reflects
the diversity of our country – and keeping them engaged for a decade or more –
requires purposeful precision engagement.
As the program has built an infrastructure to enroll participants, collect data, curate information, and facilitate physical
measurements and biospecimen collection (PM&B), HCM has been a vital partner since the beginning. We have built
a robust engagement infrastructure to reach, educate, and motivate individuals from communities that have been
historically underrepresented in research (UBR) to participate in the program.
Our engagement approach is grounded in best practices and fueled by the knowledge that impactful engagement
requires you to meet people where they are – not only where they live, work, and play, but also where they are
along their engagement journey. This journey begins with awareness, moves towards enrollment, and nutures ongoing
participation in the All of Us Research Program. To enable sustained, impactful engagement with potential participants,
we have built relationships with key influencers based upon trust, transparency, and bidirectional communication – the
same core values central to the All of Us Research Program.
What we have accomplished. Deep relationships across key communities have been leveraged and community-engaged
approaches used to design, develop, and deliver tools and experiences for multiple audiences. Activities
and results have been tracked to inform the iteration process to improve efficiencies. Impact and scale have been
achieved through partnerships with national organizations with the infrastructure to localize the program. Through
our trusted partnerships, we have brought the All of Us Research Program to neighborhoods, college campuses,
churches, professional conferences, festivals, and other venues where potential participants live, work, and play.
HCM has built, nurtured, and engaged a national network of 1,214 organizations. Our
relationships with these organizations resulted in 902 of them undertaking at least one learning
activity about All of Us. We created the opportunities, tools, and trainings that resulted in 412 of
these organizations taking the next steps to engage with their community in at least one activity,
which is a 46.7 percent activation rate.
Where we are going. Over the next five years, this infrastructure will be expanded to increase awareness of
All of Us, motivate individuals to enroll, engage with participants to retain them over a decade or more, and
nurture an ecosystem of researchers hungry to use the data. The individual components of the engagement
infrastructure will be housed in the new Engagement Innovation Network (Network) and fueled by a new
Engagement Incubator (EI). The EI will provide a community engagement structure that employs community-based
and participatory-engagement approaches to develop experiences for multiple audiences that can be
delivered in a variety of settings, which are replicable and scalable. Best practices will enable efficiency and
impact. Program data and metrics will be used to develop and optimize our strategy over time, and activities
will be aligned to keep pace with key milestones.
HCM is comprised of the nation’s leading experts in community, provider, multicultural, and digital engagement, as well
as experiential learning. We have expanded our team to meet the challenges of this next phase of engagement work
and have brought on new team members including: Brightline Interactive and Notiontheory to expand our ability to
develop a range of digital experiences on a variety of platforms; as well as the National Minority Quality Forum (NMQF)
to bring a critical convening ability and reach into the minority research community.
The impact of our activities to date, as well as our vision for engagement over the next five years, will put the program
on a path to reach its ambitious goals, while remaining true to its core values and enable research that will improve
health outcomes for individuals and communities that have been historically underrepresented in research.
HCM is pleased to submit this proposal in response to the funding opportunity OT-PM-19-004. Our submission is in
response to all five task areas.

Public health relevance
No Text